Identifying and characterizing mortality hotspots in low- and middle-income countries

PROJECT SUMMARY/ABSTRACT
Despite decades of average national reductions in mortality among children and adults living in the
world’s poorest countries, some regions have been eft out of this broad reductions in mortality. This
project aims to identify the location of and characterize these “mortality hotspots,” where child or adult
mortality are exceptionally high and on track to remain the among the world’s highest reach as the
Sustainable Development Goals target year of 2030 approaches. To address this gap and identify paths for
improving health among those living in mortality hotspots, this proposal includes three aims. First, we
will obtain spatially granular estimates of mortality among infants, children, and adults in low- and
middle-income countries using existing and novel spatial interpolation approaches. Second, we will
identify mortality hotspots by projecting, comparing, and reconciling different mortality estimates.
Finally, we will classify and characterize hotspots based on their proximity to armed conflicts and ease of
access for public health interventions. Identifying those hotspots that relatively safe and easier to reach is
a step enabling targeting of public health interventions for near-term improvements. The results will
inform targeted programs to reduce mortality and disease burden among the world's most vulnerable
populations, ultimately advancing global public health efforts.

Public health relevance
Modified Public Health Relevance Section Achieving the Sustainable Development Goals requires a focused effort on regions with exceptionally high mortality rates. This proposal uses geospatial methods and machine learning to identify such “mortality hotspots” in low- and middle-income countries, where mortality among children and adults is high and not on track to meet the Sustainable Development Goals. We will differentiate hotspots in conflict-ridden and remote areas from those in more accessible areas to better direct healthcare and public health interventions where they are most needed.